Cortical and subcortical dynamics in the central auditory system across learning and overtraining

PROJECT SUMMARY
As animals interact with their environment, they build and accrue sound associations with behaviorally relevant
outcomes. The mammalian auditory system can be modified by experience and by behavioral context and
supports the ability to build these associations. The auditory cortex (AC) supports the ability for animals to
learn that particular sounds can signal rewards. The neural responses in the primary auditory cortex (A1) can
be re-shaped by audiomotor learning, taking the form of changes at the single-neuron and population level.
This learning-induced plasticity decreases after animals are trained at expert levels of behavioral performance
for several weeks until the cortical map appears to renormalize and neural responses revert to a near pre-
learning state. The plasticity that emerges across learning is not preserved in the cortex during the overtraining
phase, yet animals are able to retain task performance. The overall objective of this proposal is to if A1 tutors
or offloads these combined representations of sound and action to another pathway for long-term use, which
supports long term execution of the task and the renormalization of A1. Our central hypothesis is that the A1
tutors subcortical auditory regions—the medial geniculate body (MGB) and the inferior colliculus (IC)—
which subsequently store audiomotor associations. I will address this question in two aims. In Aim 1, I will
determine the spatiotemporal dynamics of plasticity in the IC, MGB, and AC across learning and overtraining.
In Aim 2, I will identify the causal contributions of the MGB and the IC at the expert level. To do this, I will train
mice on an auditory go/no-go task where mice learn to lick to a pure tone for a water reward (S+) and withhold
licking to another tone (S-) to avoid a timeout. We use large-scale, two-photon mesoscopic imaging to monitor
neural activity in IC neurons, MGB axons, and A1 neurons over the entire course of learning and overtraining
(28 days). I developed a new surgical preparation which allows the implantation of a single cranial window over
the IC and the AC to enable simultaneous calcium imaging of both regions and the feedforward projections
from the MGB to the AC. By tracking the same cell bodies and axons across a month of training, we examine
the sequence of stimulus-related and non-stimulus related plasticity and the nature of how learning and
overtraining impact these processes across the sensory hierarchy. Using a combination of state-of-the-art
optical tools, temporally precise optogenetics, large-scale calcium imaging, and custom computational
analyses and tools, these experiments will help us understand the nature of cortical-subcortical interactions
that support auditory learning and memory consolidation along three processing stations in the central auditory
system.

Public health relevance
PROJECT NARRATIVE Linking sound associations with behaviorally relevant outcomes is a critical task of the auditory system, as we build and accrue sound associations throughout our lives. The auditory cortex (AC) has been implicated as a site of learning-related plasticity, but the extent to which this plasticity is offloaded to its subcortical antecedants, the medial geniculate body (MGB) and the inferior colliculus (IC), remains unknown. The proposed research will provide fundamental insights into auditory cortical-subcortical interactions over learning and long-term performance, and can help inform strategies to increase central auditory plasticity to compensate for peripheral forms of hearing loss.